Child Health After Assisted Reproductive Technology: A Population-Based Study

DESCRIPTION (provided by investigator): Infertility affects an estimated 12 percent-15 percent of women of reproductive age. The use of fertility enhancing therapies, including Assisted Reproductive Technologies (ART), has risen steadily in the United States, with an estimated 1 percent-3 percent of births involving ART. Numerous studies have reported significantly higher risks of adverse perinatal outcomes in assisted-versus spontaneous-conception pregnancies. Infertility and sub fertility diagnoses, independent of ART, can also result in higher rates of adverse pregnancy outcomes. Documenting the added effect of ART, beyond underlying sub fertility, on child health outcomes remains a challenge. This applications describes an innovative collaboration between Boston University's School of Public Health, the Massachusetts Department of Public Health, the Society for Assisted Reproductive Technology, and the Centers for Disease Control and Prevention. The collaboration creates a unique longitudinal, population-based, source of data that combines detailed clinical information on ART treatment and infertility diagnoses for the resultant live births and fetal deaths from 2004 through 2011, with the Massachusetts Pregnancy to Early Life Longitudinal (PELL) Data System. PELL contains longitudinal data on pregnancy, births, deaths, hospital utilization, birth defects and public program participation including Early Intervention. The resulting database will track reproductive and child health outcomes to 3 years of age among three groups: babies conceived through ART (~18,000), and those not conceived through ART to subfertile women (~5,000) and those conceived to fertile women (~354,000). This project addresses key limitations of prior ART research (limited subfertility comparison groups, and lack of population-based data and longitudinal child health measures). Two broad hypotheses will be tested: (1) children born from ART treatments are at significantly higher risk of compromised fetal, perinatal, infant, and early childhood health outcomes compared to the two comparison groups, and (2) risk of adverse infant and child health outcomes will vary by ART treatment parameters, infertility diagnoses, and their interaction. The treatment parameters will include source of gametes; state of oocytes or embryos; stage of the embryo; micromanipulation; number of embryos transferred; early fetal loss; and number and outcome of prior treatment cycles. In both cases we will test these hypotheses at three age periods: 1) fetal/perinatal; 2) infant health to one year; and 3) child health to three years. The analyses will proceed in five stages: 1) univariate analyses; 2) unadjusted bivariate analyses; 3) multivariate analyses adjusted for known confounders; 4) subgroup analyses; and 5) path analysis to assess the differential effect of ART treatment parameters and infertility diagnoses, as well as the magnitude of the overall effect of ART, and the direct and indirect effects of plurality on perinatal and child health outcomes in an eight-year, population-based sample. The result will be the largest, most refined analysis ever completed of child health outcomes associated with ART.

Public health relevance
PUBLIC HEALTH RELEVANCE: Research has shown that children born after infertility and assisted reproductive technology (ART) treatments are at greater risk for adverse health outcomes, although the generalizability of prior studies has been hampered by small sample sizes and the lack of a subfertility comparison group. As the use of infertility treatments continue to rise, it is important to determine how much of this increased risk is related to the ART treatment rather than the underlying infertility, and if there are residual effects extending into early childhood. The proposed project will link ART clinical data from 2004 to 2011 to the Massachusetts Pregnancy to Early Life Longitudinal birth and fetal death file (resulting in approximately 18,000 ART assisted births, 5,000 births with no ART but other subfertility indicators, and 380,000 other births), facilitating the largest and most comprehensive U.S. study to date on infertility, ART and child health from birth to age three. Project Narrative Research has shown that children born after infertility and assisted reproductive technology (ART) treatments are at greater risk for adverse health outcomes, although the generalizability of prior studies has been hampered by small sample sizes and the lack of a subfertility comparison group. As the use of infertility treatments continue to rise, it is important to determine how much of this increased risk is related to the ART treatment rather than the underlying infertility, and if there are residual effects extending into early childhood. The proposed project will link ART clinical data from 2004 to 2011 to the Massachusetts Pregnancy to Early Life Longitudinal birth and fetal death file (resulting in approximately 18,000 ART assisted births, 5,000 births with no ART but other subfertility indicators, and 380,000 other births), facilitating the largest and most comprehensive U.S. study to date on infertility, ART and child health from birth to age three. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS AND HYPOTHESES. Infertility affects an estimated 12-15 percent of women of reproductive age.1 The use of fertility-enhancing therapies, including assisted reproductive technologies (ART), has risen steadily in the United States. Numerous studies have reported significantly higher risks of adverse perinatal outcomes in assisted- versus spontaneous-conception pregnancies, including an excess of prematurity, growth restriction, low birthweight, and birth defects.2-4 Subfertility, defined as spontaneous conception after a diagnosis of infertility or a prolonged time-to-pregnancy, increases the risk of adverse health outcomes, particularly preterm birth.5, 6 Additionally, specific infertility diagnoses have been associated with reduced birthweights, although the results are inconsistent and the mechanisms unclear. These risks may be related to the underlying cause of the infertility, or factors involved in the ART treatment itself, such as micromanipulation of the embryos, use of donor gametes, or prior fresh or frozen state of the embryo. As the use of ART continues to rise, it is important to determine whether the excess risk of adverse health outcomes are related to the cause or to the treatment, and if there are residual effects extending into early childhood. In 2004, the President's Council on Bioethics called for such long-term studies to assess ART and child health concerns, but this need has not yet been addressed. The State of Massachusetts is ideally suited for studying the effect of infertility and ART on child health at the population level. First, Massachusetts is one of only 22 states that collects data on infertility treatment on its birth certificate, and has done so since 1996, longer than any other state. Second, Massachusetts is one of only 14 States with mandated private insurance coverage for infertility therapy, reducing an important barrier to care. As a result, Massachusetts ranks first in the highest proportion of multiple births and ART procedures per population, and fourth in total number of ART cycles and ART births in the United States.7 Third, all seven ART programs in Massachusetts report their data directly to the Society for Assisted Reproductive Technology Clinic Outcomes Reporting System (SART CORS) national database. Fourth, for the first time, SART has produced individual-level rather than cycle-based data by linking ART cycles of women who were treated in Massachusetts clinics or were Massachusetts residents during 2004-20068, 9; SART will link all cycles for these three groups of women through 2011. Fifth, Massachusetts has a unique, longitudinal linked data system that contains multiple indicators of child health and development from pregnancy through early childhood, and can provide population-based comparison groups of children conceived without ART by women with and without indicators of subfertility. The Pregnancy to Early Life Longitudinal (PELL) data system, an academic- government partnership between the Boston University School of Public Health (BUSPH), the Massachusetts Department of Public Health (MDPH), and the Centers for Disease Control and Prevention (CDC), has annually linked all Massachusetts birth and fetal death certificate records since 1998 with the birth-related hospital discharge records, as well as with death certificates of all children and their mothers, non-birth hospital discharge records, maternal and child observational stays, emergency department visits, Early Intervention program participation, and the Massachusetts Birth Defects Registry. We propose to link the SART CORS clinical database with the population-based PELL data system for residents of Massachusetts and non-resident women giving birth in Massachusetts during 2004-2011: an estimated 18,000 ART births and 380,000 total live births among women who used private health insurance or were self-pay at the time of delivery (Medicaid does not cover infertility services). The purpose of this research proposal is to study whether ART is related, independent of subfertility status, to short- and long-term adverse health effects during fetal development, the perinatal period, and early childhood to age three, through a clinical and epidemiological population-based approach. This is the first study of its kind in the US using these novel linked data, and will provide the foundation cohort for a longitudinal study of children born from ART treatments in the Commonwealth of Massachusetts. The four institutions collaborating on this project (BUSPH, SART, MDPH, and CDC) have been working together towards this goal since September, 2006. A detailed Memorandum of Understanding (MOU) has been developed describing the guiding principles for the collaboration, study activities, principles for the management of the data and data linkages, and the roles and responsibilities of each partner institution (see Appendix B). The collaboration will be known as the Massachusetts Outcomes Study of Assisted Reproductive Technology Collaborative or the MOSART Collaborative. There are two main goals of this study: (1) to evaluate the contribution of ART pregnancies to compromised child health outcomes on a population-based level in Massachusetts using two comparison groups: pregnancies and births to mothers without ART but with other subfertility indicators, and all other non-ART pregnancies and births; and (2) to evaluate the contribution of specific ART treatment parameters, infertility diagnoses, and their interaction to compromised child health outcomes. The compromised health outcome measures include: multiple gestations; morbidity (perinatal, infant, and childhood to age three); and mortality (fetal, neonatal, postneonatal, infant, and childhood, up to age three). Morbidity outcome measures will include prematurity (<37 weeks gestation), small-for-gestational-age, low birthweight (<2500 grams), newborn length of stay, birth defects, utilization of post-birth hospital-related services (including inpatient admissions, emergency department visits, and observational stays), and referral/enrollment in Early Intervention services up to age three years. The hypothesis to be tested is that children born from ART treatments are at significantly higher risk of compromised fetal, perinatal, infant, and early childhood health outcomes compared to children conceived without ART, with and without maternal indicators of subfertility. Plurality will be evaluated as a compromised fetal/perinatal health outcome; infant health and child health outcomes to age three will be evaluated separately by plurality. 2.1. Study Area 1: POPULATION-BASED COMPARISONS Assess the population-based effects of ART treatment on pregnancy, birth and child health outcomes. Area 1 Hypothesis: Pregnancies conceived through ART, compared to pregnancies conceived without ART to (1) women with subfertility indicators and (2) women without subfertility indicators, have a higher risk of compromised fetal, perinatal, infant, and early child health outcomes. In addition, the effect of specific infertility diagnoses and ART treatment parameters, if known, on outcomes will be explored. This hypothesis will be tested for the following outcomes during three time periods: fetal/perinatal, to one year of age, and to three years of age: i. Fetal/Perinatal Outcomes: multiple gestations, perinatal morbidity (prematurity, low birthweight; small for gestational age, newborn hearing impairment); and fetal mortality and neonatal mortality. ii. Infant Health Outcomes to One Year: infant morbidity (birth defects; use of hospital-based services, including inpatient admissions, emergency department visits, and observational stay visits; referral to Early Intervention services), and postneonatal and infant mortality. iii. Child Health Outcomes to Three Years: childhood morbidity (use of hospital-based services, participation in Early Intervention services) and childhood mortality. 2.2. Study Area 2: ART DIAGNOSES AND TREATMENT COMPARISONS Assess the effect of ART treatments, infertility diagnoses, and their interaction, on pregnancy, birth, and child health outcomes. Area 2 Hypothesis: Pregnancies conceived through ART will differ in their risks for compromised fetal, perinatal, infant, and early childhood health outcomes by ART treatment parameters, infertility diagnoses and their interaction. This hypothesis will be tested by the following infertility diagnoses: male factor only, female factors only (including endometriosis, ovulation disorders, diminished ovarian reserve, tubal factors, uterine factors, other factors), both male and female factors, and unexplained. The ART treatment parameters to be evaluated include the following [(*) indicates the reference group]: i. Source of gametes and embryos: autologous* versus donor (oocytes and/or sperm); ii. State of oocytes or embryos: fresh* versus thawed (oocytes or embryos); iii. Embryo stage: cleavage (day 3 at transfer)* versus blastocyst (day 5-7 at transfer) iv. Micromanipulation: none* versus micromanipulation (intracytoplasmic sperm injection and/or assisted hatching); v. Embryos transferred: number of embryos transferred (1* versus 2 versus 3 or more) vi. Early fetal/implantation loss: plurality at birth less than plurality at conception (no* yes) vii. Prior ART treatments and outcomes [during 2004-2011]: number of prior cycles (none,* 1, 2+); prior ART conception (no,* yes); prior live birth from ART treatment (no,* yes).